Decipher and target GABA metabolism and GABA receptor-mediated signaling in autoimmune diseases

Summary:
Properly allocating metabolic resources is crucial for mounting energetically costly T cell mediated-immune
responses. In addition, cellular metabolic programs interact with cell-surface receptor signaling pathways by
providing metabolites as ligands. This proposal aims to understand the role of γ-aminobutyric acid (GABA) in
regulating T cell inflammation and explore the potential therapeutic value of targeting GABA in animal models of
inflammatory and autoimmune diseases. An integrated analysis of the extracellular metabolome, stable isotope
traced metabolic pathway analysis, and metabolic transcriptome revealed that GABA is one of the most abundant
metabolites produced through glutamine and arginine catabolism in CD4+ T effector cells. Expressing 4-amino-
butyrate aminotransferase (ABAT) funnels GABA as an anaplerotic substrate into the tricarboxylic acid cycle to
maximize carbon allocation in promoting TH17 cell differentiation. By contrast, the absence of ABAT activities in
iTreg cells enables GABA exporting to the extracellular environment and acting as an autocrine signaling metab-
olite to suppress T cell inflammation. Accordingly, genetically or pharmacologically ablating ABAT activity in T
cells suppresses inflammation in vivo. Conversely, genetically ablating GABA(A) receptor in T cells deteriorates
inflammatory responses.
Hence, we hypothesize that GABA functions as a metabolic and signaling gatekeeper in coordinating carbon
assimilation and receptor signaling response to governing CD4 T effector cell proliferation and inflammatory
response. The aims of this proposal are to 1) decipher the molecular and signaling mechanisms that control
GABA metabolism in T cells; 2) determine the outcomes of modulating GABA metabolism and receptor signaling
in regulating the effector function of T cells; 3) develop and test complementary enzymatic, genetic, and meta-
bolic strategies to modulate inflammatory response and autoimmunity in animal models of multiple sclerosis and
rheumatoid arthritis. Collectively, the expected outcomes of this project are significant as it will reveal the funda-
mental principles of the emerging connections between cell metabolism, immune signaling, and T cell differenti-
ation. These studies are critical to developing novel approaches and therapeutic interventions that improve clin-
ical outcomes of inflammatory and autoimmune diseases.

Public health relevance
Project Narrative With the increase in auto-immune diseases and emerging concerns of compromised immunity in our aging culture and vulnerable children, understanding T cell signaling, metabolic processes, and the resources required for proper immune response and functioning are extremely relevant to public health. This project explores how metabolism is controlled in T cell immune responses at the level of precise biochemical reaction and molecular interactions, which are amenable to pharmacologic manipulation. This proposal will enable developing novel therapeutic interventions by targeting the metabolic and signaling pathways for T cell-mediated inflammatory and auto-immune diseases, which aligns with the NIAID’s mission to conduct and support basic and applied research to understand better, treat, and ultimately prevent infectious, immunologic, and allergic diseases.